Determination of Hair Cell Fate from Postnatal Cochlear Supporting Cells

Summary
Blocks to regeneration of hair cells by an unknown mechanism exist in the adult mammal, but we have
recently shown that cochlear hair cells have a capacity for spontaneous regeneration in the first few postnatal
days. We have recently discovered that Wnt signaling stimulates generation of hair cells from progenitor cells
in the newborn cochlea, and we hypothesize that downstream targets of the Wnt pathway become less
accessible with age of the cochlea. Our preliminary data show that histone deacetylase inhibitors, which
preserve acetyl groups on histones, increase the proliferation of newborn cochlear supporting cells and
promote hair cell differentiation in the newborn and to a lesser extent the adult inner ear. We seek to learn both
the nature of chromatin changes and the potential to reverse them with epigenetic drugs and CRISPR dCas9
mediated epigenetic modifications.
Although our recent work has provided an important proof-of-principle for hair cell replacement in the adult,
regeneration was limited. Here, we assess the response to inhibition of epigenetic modifiers of both the
newborn and adult cochlea with a focus on the control of expression of transcription factor Atoh1 and its
downstream targets. We assess the effects of 3 epigenetic modifiers that we propose to be key to enhancer-
based activation of genes required for HC differentiation. In Aim 1, we assess the effects of these modifiers,
Tcf4, Setd7 and Lsd1, on epigenetic marks and chromatin accessibility in cochlear organoids and we ask
whether manipulation of their level of expression can reverse chromatin inaccessibility and increase
differentiation of hair cells. In Aim 2 we assess chromatin modification mediated by Lsd1 and HDAC inhibition
for effects on Atoh1 activation and differentiation of hair cells. In Aim 3, we test our hypothesis that
manipulation of epigenetic changes through these modifiers of chromatin will increase hair cell differentiation in
the damaged cochlea. We test the epigenetic modifiers and inhibitors for their effect on hair cell regeneration in
a noise damage model of mouse deafness. Through these experiments, we ask a crucial series of questions
on epigenetic mechanisms in hair cell regeneration and recovery of function.

Public health relevance
Project Narrative Hair cells of the inner ear are responsible for detection of sound and motion. Loss of hair cells is a major cause of hearing and balance disorders. The results of hair cell loss are permanent as the adult mammalian organ of Corti - a mosaic of nonsensory supporting cells and sensory hair cells - does not have the capacity to regenerate hair cells, and currently, there is no treatment capable of arresting or reversing this hearing loss. In this proposal, we determine the role of epigenetic factors in the regeneration of hair cells. The results could lead to new treatments for these debilitating conditions.